Targeting Polo-Like Kinase 1 in Prostate Cancer to Enhance Therapeutic Efficacy

Title: Targeting Polo-like kinase 1 in prostate cancer to enhance therapeutic efficacy
Abstract
Prostate cancer (PCa) is the second most common cause of cancer death in men in the US. Over the past
several decades, androgen deprivation therapy has been the primary therapeutic option for patients with
advanced PCa; however, the majority of patients developed into a poor prognosis stage of castration-resistant
prostate cancer (CRPC), which eventually led to mortality. And the current therapeutic agents for CRPC
patients only extend survival by around 2.5 - 5 months. Therefore, novel and effective therapeutic strategies for
CRPC patients are urgently needed. The long-term goals of this study are to identify druggable signaling
pathways that offer more effective treatment options for patients with CRPC. The objective is to identify the role
of Plk1/p62/Nrf2 signaling pathway in CRPC, and to exploit the potentially therapeutic strategies that could be
benefit the CRPC patients. The central hypothesis is that Nrf2 is activated by a noncanonical mechanism
involving p62 phosphorylation by Plk1 in CRPC. Our hypothesis will be tested by pursuing Three Specific Aims:
(1) to determine the novel role of Plk1 as regulator of cellular response to oxidative stress. (2) examine the role
of Plk1/p62/Nrf2 axis in tumor growth in mouse models. And (3) whether inhibition of Plk1/p62/Nrf2 signaling
pathway enhance the efficacy of CRPC therapy. The expected results will reveal a novel molecular mechanism
to show how Plk1 contributes to PCa progress, and will open up new avenues for application of Plk1 inhibitors
as a therapeutic option. The team, with expertise in Plk1 in mouse models, Plk1 in cancer cell biology, PCa
pathology, GU oncology and biostatistics, will be able to finish the proposed research in a timely manner.

Public health relevance
Narrative The proposed research is relevant to public health because it focuses on a novel therapeutic strategy for castration-resistant prostate cancer. These studies will establish new avenues of investigation to develop improved therapeutics to treat this deadly disease and to greatly improve patient outcome. Thus, the proposed research is relevant to NCI's mission of fostering creative discoveries and innovative research strategies for protecting and improving health and reducing the burdens associated with cancer.